Trans-ancestry, single-cell multiomics dissection of IBD-associated loci in CD4 memory T cells

PROJECT SUMMARY/ABSTRACT
Crohn’s disease and ulcerative colitis, the two major forms of inflammatory bowel disease (IBD), affect ~3.7
million Americans and Europeans, and several hundred thousand more worldwide. Genome-wide association
studies have identified more than 200 IBD loci, but distinguishing causal genetic variants from non-causal
variants in linkage disequilibrium, and understanding how non-coding, presumably regulatory variants with the
strongest association signals in most IBD loci confer risk are challenges for functional and clinical translation.
Multiomic data integration and epigenetic fine mapping in IBD-relevant cell types and contexts can bridge
knowledge gaps between statistical genetic associations and a better understanding of underlying pathogenic
mechanisms. A prime example of a non-coding locus with multiple blocks of IBD-associated variants in linkage
disequilibrium is the chromosome 5p13 locus ~250 kb from PTGER4 that is one of the most significant findings
from genetic studies of IBD in both European and African American ancestry groups. PTGER4 encodes EP4,
one of two major PGE2 receptors on T cells. PGE2, together with IL-1β and IL-23, which also have receptors
encoded by IBD risk loci genes, are overexpressed in IBD tissues and modulate Th17 immune cell development
and plasticity. Non-steroidal anti-inflammatory drugs inhibit prostaglandin synthesis and may cause flares of IBD,
possibly due to disruption of normal immune regulation. The aforementioned rationale motivated us to perform
single-cell trimodal omics assays for transposase accessible chromatin (ATAC), gene expression, and cell
surface protein epitope expression in paired T cell samples from healthy young adults that were exposed in ex
vivo experiments to activation stimuli, IL-1β and IL-23, with or without PGE2. Our pilot study shows a significant
enrichment of IBD-associated variants in T cell subtype-specific, especially CD4 memory T cell subtype-specific,
ATAC peaks and significant inhibition of T cell activation by PGE2 in multiple T cell subtypes. We hypothesize
that IBD-associated genetic variants interfere with normal inhibitory effects of PGE2 on T cell activation in specific
CD4 memory T cell subtypes that are also exposed to activation stimuli, IL-1β and IL-23. We propose a trans-
ancestry, single-cell trimodal omics approach to test our hypothesis. In Aim 1, we will perform large-scale, single-
cell trimodal omics experiments in CD4 memory T cells from European and African American/West African
ancestry study subjects and build a first-in-class single-cell trimodal omics atlas of CD4 memory T cells. In Aim
2, we will perform integrative and trans-ancestry analyses of single-cell trimodal omics and genetic data to dissect
IBD-associated loci and to examine similarities and differences of regulatory networks between the two ancestry
groups. We expect to identify the most probable non-coding IBD risk variants and their most probable gene
targets in specific CD4 memory T cell subtypes exposed to activation stimuli, IL-1β, IL-23, and PGE2. Our project
will complement ongoing research by NIDDK IBD Genetics Consortium investigators and will also be useful for
the interpretation and prioritization of genetic variants for functional studies in other immune-mediated diseases.

Public health relevance
PROJECT NARRATIVE Intensive searches of the human genome have identified more than 200 genetic risk loci for inflammatory bowel disease. However, understanding how these genetic factors confer risk for inflammatory bowel disease and clinical application are unmet challenges. We will use a cutting-edge single cell trimodal omics approach to study specific subtypes of immune cells isolated from study subjects with European, African American or West African ancestry to gain a better understanding of how human genetic variations predispose individuals to the dysregulation of the immune system that underlies inflammatory bowel disease.